Targeting Immune Escape in CML/MPN Transformation

Myeloid neoplasms such as chronic myelogenous leukemia (CML) and myeloproliferative neoplasms (MPN) may
over time transform from a chronic phase (CP) into, respectively, blast crisis (BC) or secondary acute myeloid
leukemia (sAML). Both of these conditions are poorly responsive to currently available therapies and novel
approaches are urgently needed. To this end, we have studied distinct mechanisms of BC/sAML transformation
to discover new targets and develop corresponding therapeutic approaches that prevent and cure disease
transformation. A common goal of all these studies is to eliminate leukemia stem cells (LSCs) that drive leukemia
growth and BC/sAML transformation. In addition to mechanisms of BC/sAML transformation intrinsic to LSCs,
we have recently gained insight into those that are extrinsic to LSCs and that involve transformation of the normal
bone marrow (BM) microenvironment (or niche) into a “leukemic” one. Herein, we focus on leukemogenic
mechanisms that induce T cells' loss of activity and exhaustion and that ultimately drive LSCs' escape from T
cells' antileukemic immune surveillance. To this end, microRNAs (miRNAs) are small non-coding RNAs that
target messenger RNAs and regulate levels of the corresponding proteins. MIR142, a highly conserved “gene”,
encodes miR-142, which is involved in the development and regulation of hematopoiesis and native and adaptive
immunity. In humans, MIR142 has been found mutated in lymphoma and AML, but not in CML or MPN. We
recently showed that miR-142 downregulation (deficit) occurs in CD34+CD38- LSCs from BC CML patients
compared with those from CP CML patients, leading us to postulate its contribution to the evolution of CP-LSCs
into BC-LSCs. While investigating these findings in mouse models, we observed that compared with the
Mir142+/+BCR-ABL mouse (a CP CML model), the Mir142−/−BCR-ABL mouse (a BC CML model) presented with
a profound T cell lymphopenia, and a significant reduction of T cell activity. To this end, we also observed: a.
reduced miR-142 level and activity in T cells from BC CML patients compared with those from CP CML patients;
b. an association of miR-142 deficit with increased PD-1 expression and T cells' exhaustion; and c. correction of
miR-142 deficit with a novel synthetic miR-142 mimic (CpG-M-miR-142), which restored the antileukemic activity
of T cells from both human and murine BC/sAML models. Thus, we hypothesize here that miR-142 deficit is
acquired by T cells during BC/sAML transformation and contributes to the phenotypic evolution of CML/MPN into
BC/sAML via mechanisms that allow LSCs to escape from T cell antileukemic surveillance. To prove our
hypothesis, we propose three specific aims (SA): SA#1: To determine the role of the T cells' miR-142 deficit in
BC/sAML transformation. SA#2: To dissect the molecular mechanisms through which miR-142 deficit mediates
T cells' loss of activity during BC/sAML transformation. SA#3: To target miR-142 deficit in T cells in order to
prevent and/or cure BC/sAML transformation. Our ultimate goal is to obtain IND-enabling evidence that CpG-M-
miR-142 is a novel targeting therapeutic that restores T cells' immunity, and in turn eliminates BC/sAML LSCs.

Public health relevance
Project narrative (relevance): Despite appropriate treatments, chronic blood disorders such as chronic myelogenous leukemia (CML) and other myeloproliferative neoplasms (MPN) can transform into more aggressive conditions, i.e., respectively blast crisis (BC) CML or secondary acute myeloid leukemia (sAML), which are very poorly responsive to currently available treatments. This proposal seeks to understand the mechanisms through which deficit of a molecule called miR- 142 causes a loss of function of the immune system that favors BC/sAML transformation and to target these mechanisms with new approaches that address the otherwise unmet need for effective therapies for patients with these conditions. To this end, we will develop a novel drug called CpG-M-miR-142 to restore levels of miR- 142, enhance immune system function and eventually block disease transformation in these otherwise poor-risk patients.